Deciphering and targeting a non-genetic driver pathway in hepatocellular carcinoma

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) accounts for nearly 31,000 deaths annually in the United States alone.
Factors that epigenetically silence an HCC tumor suppressor gene have the potential to promote
tumorigenesis and thus may provide novel drug targets for HCC therapies. Using a genome-scale shRNA
screen, we identified BCL6 as a putative and novel HCC driver gene. BCL6 is a transcriptional repressor with
no previously documented role in HCC development and progression. We found that BCL6 was sufficient to
transform cultured immortalized hepatocytes and promote HCC tumor growth in mouse subcutaneous
xenografts. These oncogenic effects of BCL6 were dependent upon the ability of BCL6 to cause transcriptional
repression because a transcriptional repression activity defective mutant of BCL6 failed to transform
hepatocytes and promote tumor growth in mice. Based on our preliminary results, in this application we will
establish the role of BCL6 as a driver of HCC, determine the mechanism by which BCL6 promotes tumor
growth, and evaluate novel BCL6 targeting small-molecule inhibitors for HCC therapy. In Aim 1, we will
establish the role of BCL6 in initiation and progression of hepatic tumorigenesis using a series of
complementary mouse models that recapitulate characteristic features of HCC, including a mouse model of
liver fibrosis (cirrhosis). This model recapitulates cirrhosis which is a cardinal feature of HCC. Additionally,
based on our preliminary results that BCL6 inhibition in HCC cells increases their probability of getting cleared
by T-cells, we will also use a mouse model with humanized immune system to study the impact of BCL6 in
HCC progression in the context of a functional human immune system. In Aim 2, based upon the results of our
RNA-seq and further follow up analysis, we will determine if epigenetic silencing of tumor suppressor HHIP and
the zinc transporter ZIP14 by BCL6 is necessary for it to drive hepatic tumor growth. In Aim 3, we will evaluate
our novel BCL6 inhibitors in pre-clinical mouse models of HCC, including HCC patient-derived xenograft (PDX)
models for HCC therapeutics. In preliminary experiments, we have developed a novel small-molecule inhibitor
designed to target the BTB domain of BCL6 and thereby disrupt its interaction with its co-repressors SMRT,
NCOR and BCOR. We found that this novel BCL6 inhibitor L2-12019 inhibited the HCC cell growth in culture
and in a human HCC xenograft-based mouse model. In Aim 3 studies, we will rationally design and evaluate
new L2-12019 analogs to improve drug-like properties. The lead analog (with improved potency, selectivity,
stability and solubility) will be tested with L2-12019 in pre-clinical mouse models of HCC and its efficacy will be
compared with existing BCL6 inhibitors. Collectively, the results of the experiments proposed in this application
will elucidate a novel non-genetic druggable pathway that promotes HCC tumor growth and progression and
evaluate a new approach for treating HCC.

Public health relevance
PROJECT NARRATIVE Over 30,000 Americans die from hepatocellular (liver) carcinoma (HCC) every year and current treatments provide no long-term benefit, highlighting the urgent need for new and effective therapies. We have discovered that a protein called BCL6 is required for the growth of HCC tumors, and found that inhibiting BCL6 not only blocks hepatic tumor growth but also enhances the ability of the immune system to eradicate the tumor. The results of the experiments proposed in this application will establish the role of BCL6 in promoting HCC and evaluate novel small molecule inhibitors of BCL6 as a novel HCC therapy.